How cell elimination sculpts the developing cortical astrocyte population

Abstract/ Project Summary
Astrocytes are a major class of glial cells in the central nervous system (CNS) and have roles in
neurotransmitter homeostasis, ion balance, and maintenance of the blood-brain barrier. How the brain achieves
the correct number of astrocytes remains poorly understood. The establishment of proper cell numbers is vital
for a healthy CNS. Cellular elimination is a mechanism various tissues employ to sculpt developing structures
throughout the body. In the developing CNS, neuronal and oligodendrocyte progenitor cells undergo elimination,
modulating the progenitor pool size. Later, following terminal differentiation, immature cells are eliminated to
refine circuits. Despite the large body of literature describing elimination in neuronal and oligodendrocyte
populations, little is known about whether astrocytes are established similarly. Evidence suggests that immature
astrocytes are eliminated in the first postnatal week. Preliminary data indicates that during late postnatal
development, astrocyte cell number declines. This suggests that astrocytes are eliminated to sculpt the final
population, but the mechanism by which this occurs is not well understood. The goal of this proposal is to
investigate cortical astrocytes undergo stage-specific elimination during the first month of postnatal
development and determine the mechanism through which this occurs. Aim 1 seeks to determine the
precise timing of astrocyte elimination during early postnatal development and the underlying mechanism. This
will be accomplished through lineage tracing and cellular-specific ablation to determine whether microglial
engulfment facilitates the elimination of astrocyte progenitor cells. Aim 2 will investigate astrocyte elimination
during late postnatal development, how this sculpts the mature astrocyte population in the cortex, and whether
neuronal activity influences astrocyte survival.
The proposed experiments will be performed at Drexel University under the guidance of the sponsor and
thesis committee. This project incorporates a training plan with specific training in experimental design, data
analysis, scientific communication, and writing. In addition, the training plan incorporates career and professional
development through participation in local and international meetings. The overarching goal of this pre-doctoral
fellowship is to provide the training and experience needed to pursue a career as an independent researcher in
developmental neurobiology.

Public health relevance
Project Narrative Establishing the appropriate balance of cell types in the brain is vital for proper brain function. Failure to achieve this balance can impair behavior and cognition. This project focuses on astrocytes, a major population of non- neuronal cells in the brain and explores the cellular and molecular mechanisms underlying how the nervous system ensures the appropriate development of astrocyte number.